Development of a PET CCR2 Imaging Agent to Profile PDAC Microenvironment

Project Summary
Pancreatic ductal adenocarcinoma (PDAC) is a highly aggressive cancer. PDAC is the 4th leading cause of
cancer related death with a 5-year survival rate <12%, resulting in 200,000 deaths per year. Early detection of
tumor size one inch or less with surgical resection of pre-metastatic disease has the best survival benefit. Clinical
imaging is important in the early detection of small tumors. Unfortunately, no individual diagnostic imaging
technique is sufficiently accurate for the detection of small, potentially curable PDAC. PDAC has a profuse
extracellular matrix which can constitute 90% of tumor volume. A dominant cellular component of this matrix is
infiltrating immune monocytes including myeloid-derived suppressor cells (MDSCs). MDSCs contribute to tumor
progression and treatment resistance through a variety of mechanisms, ultimately culminating in failed antitumor
immune responses. As a clinical imaging modality, positron emission tomography (PET) is capable of
quantitating molecular features of MDSCs present in the PDAC that drive tumorigenesis, progression and
treatment resistance. Mechanistically, the chemokine receptor 2, CCR2, expressed on monocytes may be
instrumental in securing residence of these CCR2 positive monocytes in PDAC tumors. The monocyte
chemoattractant protein-1 (MCP-1) is a specific ligand to CCR2 and induces migration by binding to components
of the TME where MCP-1 expression is elevated. The central hypothesis of this proposal is that a 18F-CCR2 PET
imaging agent can enable functional imaging of MDSC or other monocytic cells, thereby providing valuable
insight into their role during tumorigenesis, progression or response to therapy. This hypothesis will be tested by
completing the following specific aims: 1 Synthesis of CCR2 PET imaging tracers. SA1a. Synthesis of
18F-CCR2-1 and syntheses of three backup candidates. 2. In vitro characterization of 18F-CCR2 ligands. SA2a.
In PANC-1 and MIAPaCa2 cell lines. SA2b. In mouse bone marrow derived monocytes (BMDM) and human
monocytes. 3. To test and evaluate PET imaging capability of developed 18F-CCR2 candidates. SA3a. Selective
uptake of the 18F-CCR2 probes in tumors in immune compromised rodent orthotopic models of pancreatic cancer
determined by microPET and MR imaging. SA3b. CCR2 PET ligand specificity determined by blocking with non-
radiolabeled CCR2-1 ligand followed by microPET and MR imaging. SA3c. The sensitivity and the ability to
delineate tumor margins by PET will be evaluated in comparison to histo-pathology and autoradiography to
demonstrate that a 18F-CCR2 probe specifically binds to regions associated with CCR2+ macrophage
abundance. Overall, this project will enable development of an innovative, non-invasive imaging tool that acts as
a CCR2 antagonist.

Public health relevance
PROJECT NARRATIVE Pancreatic ductal adenocarcinoma (PDAC) carries a dismal prognosis. The unmet need is our inability to provide molecular and metabolic information to characterize of the chronic inflammatory state of the pancreatic tumor microenvironment for delineating the extent of the pancreatic cancer for specific diagnosis and individualized treatments and to monitor treatment responses. The goal of this proposal is to develop a small molecule 18F-CCR2 antagonist as the positron emission tomography (PET) tracer for non-invasive molecular and metabolic imaging of PDAC.